Adapting the CHATO Communication Intervention for Diverse Nursing Home Communities

Dementia is most prevalent in Black and Hispanic older adults who are increasingly cared for in nursing
homes (NHs). Staff shortages and lack of dementia care skills limit care quality, especially in NHs with high
proportions of ethnoracially diverse residents. Care for persons living with dementia (PLWD) in NHs is
complicated by behavioral and psychological symptoms of dementia (BPSD) when residents cannot express
unmet physical and psychosocial needs. BPSD increase staff stress and time to complete care, contribute to
staff turnover and injury, and lead to use of inappropriate psychoactive medication to control resident BPSD.
Our team demonstrated that BPSD occur when staff use elderspeak (speech that sounds like baby
talk). Elderspeak features inappropriately intimate terms of endearment (diminutives such as “honey”), belittling
pronoun substitutions that imply dependence (“we” need a bath), and harsh task-oriented commands (“sit
down”). Elderspeak conveys a message of disrespect and incompetence to PLWD who react with withdrawal
or BPSD. Our prior research established that elderspeak use more than doubled the occurrences of BPSD
responses in NH residents with dementia. We later confirmed that the three-session Changing Talk (CHAT)
communication education intervention reduced staff elderspeak use that significantly reduced resident BPSD.
CHAT in online format (CHATO) has demonstrated communication knowledge and confidence gains
and is currently being testing in a national clinical trial. However, NHs serving higher proportions of diverse
residents have not shown interest in participation, despite having more frequent and serious care deficiencies
including higher rates of BPSD and antipsychotic medication use. Research has established that tailoring and
intensification approaches are often needed for interventions across care settings to reduce care disparities.
We will first engage staff in six NHs caring for diverse residents and our expert stakeholder panel to
adapt the current CHATO intervention using the ADAPT framework to increase cultural competency. We will
test the adapted intervention (CHATO-I) in a waitlist-controlled trial in 40 NHs that care for high proportions of
minority residents (<75% White, non-Hispanic). NHs will be randomized to four groups and staff will complete
the adapted intervention with high-intensity implementation support (i.e., weekly meetings, troubleshooting,
expert consultation, leadership/champion training, incentives, tablets, and technology support). We will
evaluate feasibility and acceptability (participation and completion rates) and use mixed modeling of electronic
medical record data to assess preliminary effects on resident BPSD and psychoactive medication use.
The NIA Health Disparities Framework will guide adaptation and testing in NHs serving diverse
residents with a goal of reducing health disparities (BPSD and psychoactive medication use), addressing
National Plan to Address Alzheimer’s disease goals, NIA’s milestones for nonpharmacological interventions,
and the National Academy Imperative to Improve NH care equity through culturally tailored interventions.

Public health relevance
Project Narrative The National Plan to Address Alzheimer’s disease has identified education of dementia care providers as a top priority to address the need for quality care for the population of persons with dementia that will triple in the next 30 years. This study will adapt and test online interactive training for nursing home staff that improves staff communication and reduces behavioral symptoms of persons with dementia that they care for. This research will adapt and test communication training to meet the needs of nursing homes that serve high proportions of residents of diverse races and ethnicities, to improve care and overcome dementia care health disparities.